Evaluating the effect of physical activity on sleep disruption and subclinical cardiovascular disease risk in peri- and early postmenopausal women.

PROJECT SUMMARY
Menopause is a health inflection point as risk for cardiovascular disease (CVD) increases dramatically in the
years surrounding the final menstrual period, resulting in worse health outcomes later in life. The menopause
transition is associated with bothersome symptoms including vasomotor symptoms (VMS, e.g., hot flashes and
night sweats) and sleep disturbances that can impact quality of life. Importantly, hot flashes and sleep
disturbances are now recognized to be potential markers of disease risk. Increased frequency and severity of
hot flashes have been positively associated with CVD risk factors, subclinical CVD markers, clinical
cardiovascular events, and CVD mortality. Poorer sleep quality is also associated with variety of negative
cardiovascular outcomes including subclinical CVD risk, metabolic syndrome and depression. Sleep
disruptions occur both with and independent of nighttime hot flashes, but few studies have evaluated both hot
flash-dependent and hot flash-independent sleep disruptions, and no studies to date have evaluated the
unique contribution of night sweats to sleep disruptions or CVD risk. Habitual physical activity and acute
exercise are associated with many health benefits. However, the effect of habitual or acute physical activity on
nighttime VMS and sleep disruption is unknown. Further it is unclear whether physical activity influences the
relationship between nighttime experiences and subclinical CVD risk. Therefore, the overall goal of the
proposed studies is to directly examine the role of nighttime VMS, habitual PA, and acute exercise on sleep
disruptions and subclinical CVD risk in peri- and early postmenopausal women. The aims of our study are: 1)
To quantify VMS- and non-VMS related sleep disruptions in midlife women with higher- and lower-levels of
habitual physical activity. 2) To quantify the differences in nighttime VMS experience and sleep disruptions
following acute exercise in higher- and lower-active perimenopausal women. 3) To determine whether the
relationships between subclinical CVD risk factors, nighttime VMS, and sleep disruption differ by habitual
physical activity status in peri- and early post-menopausal women. Cardiovascular disease risk rises to a
greater degree over the transition to menopause than other times in a woman’s life. These studies will have a
significant scientific impact because understanding the relationship between physical activity, nighttime VMS
and sleep disruptions, and preclinical CVD risk will improve knowledge of CVD risk in midlife women, which will
advance efforts to monitor and mediate risk, optimize therapies, and improve the health of women.

Public health relevance
NARRATIVE The research proposed is relevant to public health because cardiovascular disease (CVD) remains the #1 cause of death among women and CVD risk increases dramatically around the menopausal transition. The proposed R15 research aims to address gaps in knowledge regarding the relations between vasomotor symptoms and sleep disturbances, physical activity and subclinical CVD risk in women around the transition to menopause. This knowledge will advance efforts to monitor and mediate risk, optimize recommendations and improve the health of midlife women so that they can live longer, healthier, and more fulfilling lives.